STELLARIS 8 DIVE Multiphoton Microscope

PROJECT SUMMARY / ABSTRACT
The UC San Diego School of Medicine Microscopy Core is the largest light microscopy core facility on campus
and has been serving UCSD researchers since 2003. It is accessible by all UCSD researchers regardless of
department affiliation and currently has over 200 registered user labs across the campus. The Core enjoys strong
support from the faculty and our institutional leadership. The current array of 12 instruments at the Core includes
multiple confocal systems, light sheet, Gatan 3View serial block face scanning EM, slide scanning, lattice
structured illumination, among others. However, there is a clear gap for a cutting-edge multiphoton microscope,
which is currently lacking as a core resource on campus. Our previous Leica SP5 multiphoton system is no
longer operable, and a replacement system is urgently needed to continue with multiphoton research. Here we
seek funding to acquire a Leica Stellaris 8 DIVE (Deep In Vivo Explorer) multiphoton as our replacement
multiphoton system. The spectrally tunable detection of Stellaris 8 DIVE offers substantial advantages compared
with other multiphoton systems. The system is also equipped with integrated FLIM capabilities, which can be
readily used to generate channels based on fluorescence lifetime. Our on-site instrument demonstrations
validated Stellaris 8 DIVE as a capable and versatile system. The proposed user labs illustrate a critical need
among local investigators for the proposed system in advancing their NIH-funded research. They come from all
corners of the campus, and their research programs collectively cover a range of biomedical research fields with
many disease areas represented. If funded, the Stellaris 8 DIVE system will be extensively utilized by proposed
users and additionally will reach a potentially much larger user base as our core has proven capable of
disseminating cutting-edge microscopy technologies to the wider local research community. Adequate space
and infrastructure, capable staff, robust faculty oversight, and strong institutional commitment along with a track
record of program-leading core grant citations will ensure the effective and efficient use of the proposed
instrument for years to come. The Leica Stellaris 8 DIVE system will fill a current void in our instrumentation
portfolio and generate a sustained, powerful influence on the biomedical research enterprise at UC San Diego.

Public health relevance
PROJECT NARRATIVE This proposal seeks funding for a cutting-edge multiphoton microscope with spectrally tunable non-descanned detection and integrated FLIM capability at the well-established UC San Diego School of Medicine Microscopy Core. The instrument will support the unmet imaging needs of ten major users along with a larger number of other researchers whose NIH-funded projects span a broad spectrum of biomedical science topics. The funding of this instrument will enable our researchers to tackle new scientific questions and to make groundbreaking discoveries that will lead to the development of new diagnostics and treatments for a variety of diseases.